Next Generation ELQs for Treatment and Once-Monthly Protection Against Malaria

Project Summary / Abstract
The Medicines for Malaria Venture (MMV) recently published a “roadmap” for the types of medicines that are
needed to support the long-term goal of malaria elimination and eradication. The roadmap consists of a wish list
of target candidate profiles (TCP) and medicines (target product profiles, i.e., TPP). With the most recent revision
to the anti-malarial target candidates and product profiles the MMV highlighted the need for identifying new rapid
acting medicines for active case management while other drugs are needed for chemo-protection and chemo-
prevention with long-acting molecules, and/or parenteral formulations (i.e., TCP-2) (Burrows, JN et al., 2017,
Malaria Journal, 16:26). According to their updated roadmap new drugs are needed to protect populations
entering areas of high endemicity during the final stages of malaria elimination. And drugs with causal liver-
stage activity are needed for chemoprevention to prevent infection or outbreak of resistance during malarial
seasons. This TCP has been modeled on the combination drug atovaquone + proguanil.
As a potent and selective inhibitor of the parasite’s cytochrome bc1 complex ELQ-300 selectively targets
Plasmodium falciparum in the blood and liver stages and even kills parasites developing in the midgut of the
mosquito vector. Unlike atovaquone, ELQ-300 is a selective inhibitor of the Qi site of the targeted enzyme
complex. With support from the NIH and US DOD we created a prodrug, ELQ-331, that is more effective in vivo
due to improved oral bioavailability. This drug has been accepted by the MMV as a Preclinical Candidate for
once-weekly dosing for disease prevention. We have now identified ELQ-596 with significantly improved intrinsic
anti-plasmodial activity in vitro, enhanced efficacy in vivo in a mouse model of the disease and a more extended
bloodstream half-life relative to its progenitor. This application seeks support for optimizing the structural features
of ELQ-596 to provide a Next Generation of ELQs for once-monthly oral prophylaxis in humans. This would
simplify the dosing regimen, improve compliance, decrease the dose and associated costs, and improve
outcomes. Superior molecules will advance through a down-selection test cascade for assessment of selective
potency and lack of mammalian cytotoxicity, metabolic stability, solubility in simulated intestinal fluids, resistance
propensity and mode of action as well as efficacy against blood and liver stage malaria in mice. Prodrugs of
superior molecules will be explored to assess for enhanced oral bioavailability and antimalarial performance over
parent molecules.
Scientists with expertise in the following areas make up the collaborative investigational team: medicinal
chemistry, malaria, molecular parasitology, biochemistry, structural biology, and pharmacology.

Public health relevance
Project Narrative (for public disclosure) We already identified ELQ-300 as a selectively potent inhibitor Qi site of the Plasmodium falciparum cytochrome bc1 complex. We have recently identified an ELQ derivative that is more potent in vitro and in vivo than ELQ-300 and now seek to modify the structure of this molecule to optimize for enzyme targeting to enhance antimalarial potency, selectivity, and overall performance in vitro and in vivo in rodent models of disease infection.